Glucose Transporter Regulation in Obesity and Diabetes

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Bridge Funding for DK43051– PI: Barbara B. Kahn, MD
Long-term Overall Goal: To determine the mechanisms by which reduction of ChREBP in adipocytes causes systemic insulin resistance and impaired glucose transport in adipocytes.
Background: Carbohydrate Response Element Binding Protein (ChREBP) is the major transcription factor regulating de novo lipogenesis (DNL, fatty acid synthesis from glucose) in adipocytes. We showed that adipose-selective ChREBP KO (AdChREBP KO) causes systemic insulin resistance and impairs insulin-stimulated glucose transport in adipocytes. In humans, expression of ChREBP and genes regulating DNL in adipose tissue correlate highly with insulin sensitivity measured by clamp.
Specific Aims for One Year:
Specific Aim 1: To maintain lab staff
Specific Aim 2: To maintain mouse lines
Specific Aim 3: To generate additional preliminary data

Public health relevance
Lay summary/public health: There are few sustainable prevention strategies and not enough fully effective treatments for the growing epidemic of obesity, insulin resistance and Type 2 diabetes. Major gaps exist in our knowledge of the underlying molecular mechanisms. Attention has focused on understanding the problems with glucose or lipid metabolism separately but the mechanistic links between these pathways are poorly understood. We recently discovered that a gene-regulatory-factor in fat cells that is activated by glucose, regulates lipid metabolism in a beneficial way. Levels of this factor are low in fat of people with insulin resistance and Type 2 diabetes. In exciting new studies, we find that reduced levels of this factor in fat cells results in increased concentrations of detrimental lipids, impaired function of mitochondria (the power houses of cells), and increased production of molecules that cause cellular damage. Studies in this proposal will determine the mechanisms for these effects. This work could provide new insights into the links between obesity and Type 2 diabetes and lead to new treatment strategies.